Women-centered HIV care practices that facilitate HIV care retention and viral suppression in the presence of adverse sociocultural factors

PROJECT SUMMARY
Achieving high rates of retention in human immunodeficiency virus (HIV) care and adherence to antiretroviral
therapy leads to high rates of viral suppression, which not only reduces mortality and improves quality of living,
among people living with HIV infection, but also reduces HIV transmission within affected communities. HIV
care outcomes among women have been suboptimal; in 2014, viral suppression was 52.6% among African
Americans, 57.9% among Whites, and 59.8% among Latinas compared with 66.0% among White men.
Women living with HIV infection are more likely to face barriers to successful HIV care such as child care
burden, abuse, and extreme poverty than men. In addition, women, in particular women of color, can face
multiple layers of stigma including those related to their race, ethnicity, HIV infection, drug use, and poverty
status. Partly because the HIV epidemic initially affected mostly men, the HIV care system is not designed to
meet women's special needs. Implementing women-centered HIV care has been proposed nationally and
internationally as a way to address women's needs. However, this idea has not been well operationalized for
HIV care and has not been examined in the context of the United States health care system including the Ryan
White Program, which serves 65% of women living with HIV in the United States. Our central hypothesis is that
the more women-centric a system is, the higher the likelihood of HIV care retention and viral suppression
among women. The objective of this application is to identify effective provider and system women-centered
HIV care practices within the Ryan White Program that positively influence HIV care retention and viral
suppression among women experiencing sociocultural challenges. We will accomplish this objective with a
mixed methods study examining patient intake and billing data from women enrolled in the Miami-Dade County
Ryan White Program, conducting in-depth interviews with case managers, health care providers,
administrators, and women living with HIV, and conducting a survey of 600 women living with HIV in the Miami-
Dade County Ryan White Program. We propose the following three specific aims: 1) Identify sociocultural
factors that influence HIV care retention and viral suppression, including those unique to women and those
having a differential impact on African American, Haitian and Latina women; 2) Ascertain current and potential
health care provider and system women-centered HIV care practices that may mitigate the effect of adverse
sociocultural factors on HIV care retention and antiretroviral therapy adherence; 3) Identify specific health care
provider and system women-centered HIV care practices that most strongly influence HIV care retention,
adherence, and viral suppression among all women and in African American, Haitian and Latina women. This
project addresses the National HIV/AIDS Strategy goals to increase access to care, improve health outcomes,
and reduce HIV-related health disparities and the Trans-NIH Plan for HIV-Related Research call for research
to promote HIV care engagement and to reduce disparities in treatment outcomes.

Public health relevance
NARRATIVE There is a critical need to improve HIV care outcomes and reduce health disparities among women living with HIV infection for their individual benefit and the benefit of their communities. This project will involve analysis of Ryan White Program administrative client intake and billing data, interviews of health care providers, case managers, and administrators, and interviews with women who are patients in the Ryan White HIV care program to identify effective ways for the health care system to better serve the needs of women, especially minority women, living with HIV infection.